Lysosomal quality control through lipid remodeling

Project Summary/Abstract:
Lysosomes play essential roles in cell physiology, not only controlling nutrient recycling and cellular growth, but
also mediating the proper handling of various cellular stress. Lysosomal dysfunction is associated with aging
and many diseases such as lysosomal storage disease, neurodegeneration, and cardiovascular diseases. A
hallmark of lysosomal-related diseases is lysosomal membrane permeabilization/damage (LMP) which if not
immediately resolved can cause detrimental problems including cell death. We now start to understand that LMP
triggers multiple cellular pathways to repair damaged lysosomes. However, none of the previously described
pathways appear to be essential for rapid lysosomal repair, suggesting additional repair mechanisms. As an
attempt to find such mechanism, we recently designed and executed an unbiased proteomic screen searching
for proteins specifically enriched on damaged lysosomes. This screen led to the discovery of the
phosphoinositide-initiated membrane tethering and lipid transport (PITT) pathway as an essential mechanism
for rapid lysosomal repair. We found that LMP stimulates robust production of phosphatidylinositol-4-phosphate
(PtdIns4P, PI4P) on damaged lysosomes by type II alpha phosphatidylinositol-4 kinase (PI4K2A). Lysosomal
PI4P drives the formation of extensive membrane contacts between the endoplasmic reticulum (ER) and
damaged lysosomes by recruiting multiple oxysterol-binding protein (OSBP)-related protein (ORP) family
members. The ORPs catalyze subsequent ER-to-lysosomal transport of cholesterol and phosphatidylserine
(PS) to mediate rapid membrane repair. While cholesterol by itself increases membrane stability, PS activates
ATG2-mediated lipid transport for direct lysosomal repair. The PITT pathway is activated in response to diverse
disease-related lysosomal-damaging conditions and is expected to have enormous impact on human
pathophysiology. Remarkably, the PITT pathway not only reveals lipid transfer at membrane contacts as a
essential mechanism for lysosomal repair, but it also establishes lipid remodeling as a new platform to
understand lysosomal quality control. Through three independent projects in the next five years, our lab will
continue studying LMP-triggered lysosomal lipid remodeling for better mechanistic understanding of lysosomal
quality control and potential therapeutic applications. First, we are purifying lysosomes during and after
lysosomal repair to characterize lipid changes by lipidomics, which we believe will identify new lipid messengers
important for lysosomal quality control. Second, the PITT-mediated lysosomal cholesterol accumulation provides
a great cellular model to study cholesterol transport, and we are particularly interested in the mechanism for
cholesterol egress from newly repaired lysosomes. Finally, we are also performing chemical screens using FDA-
approved chemical library to search for small molecules that activate or block the PITT pathway. The identified
small molecules have well established protein targets, which will help define the regulatory networks for the PITT
lysosomal quality control pathway as well as delineate new strategies to improve lysosomal quality.

Public health relevance
Project Narrative Lysosomal damage is widely involved in many human diseases and can be triggered by various cellular stressors. Successful completion of this project will provide in-depth mechanistic understanding of how lipid remodeling contributes to lysosomal quality control and cellular homeostasis. These findings are expected to open new avenues to therapeutically intervene a wide array of lysosome-related diseases.